Functional genetic variants in substance use disorders

Project Summary:
GWAS assays have (and will continue to) detected loci that influence the risk for Alzheimer’s disease and
related dementias, but the loci usually contain hundreds to thousands of variants and GWAS do not identify
which variants and genes actually affect the risk. Therefore, functional assays are necessary to identify the
SNPs and genes within a locus that actually affect risk, to give insights into the mechanisms underlying the
disorders and leads to follow for better treatment. The parent grant uses high-throughput assays to identify,
within loci relevant to Substance Use Disorders, the functional SNPs that affect gene expression and the
genes and pathways they affect. This supplement will expand the scope of the funded grant to target loci
relevant to Alzheimer’s disease and related dementias, and thereby provide important data on disease
mechanisms and potential therapies.

Public health relevance
Project Narrative: This is a request for a supplement to NIH grant 5R01DA053722, entitled “Functional genetic variants in substance use disorders” in response to NOT-AG-22-025: Alzheimer’s-Focused Administrative Supplements for NIH Grants that are Not Focused on Alzheimer’s Disease. Because GWAS assays detect loci that are often broad, given linkage disequilibrium, functional assays such as those we will develop and use are necessary to narrow down which of the many SNPs within a given locus (often many hundreds) are most likely to be driving the associations, and thus give insights into the mechanisms underlying the disorders. The present supplement will expand the scope of the funded grant to develop and use high-throughput assays to test which SNPs relevant to Alzheimer’s disease and related dementias are functional.